Molecular and Cellular Basis of Cardiovascular Disease

7. PROGRAM SUMMARY
Cardiovascular disease remains a major cause of morbidity and mortality in the U.S. and is increasing
worldwide. Application of modern cell biology, genetics, 'omic and other technologies is producing remarkable
progress in our understanding of basic processes related to cardiovascular diseases, and the need for broadly
trained scientists who can adopt innovative technologies, assemble tools from different disciplines, and bridge
basic and clinical science is greater than ever. The overall goal of UCSF Training Program in the Molecular
and Cellular Basis of Cardiovascular Disease is to train investigators who will be at the cutting edge of
cardiovascular research. Toward this end we: 1) Capitalize on the outstanding research environment of the
CVRI and UCSF to provide multidisciplinary training in areas of signaling and cell biology, developmental
biology, regeneration and congenital anomalies, ion channels and arrhythmias, vascular biology and
atherothrombosis; metabolism, obesity and metabolic diseases; myocyte biology and heart failure; and
genetics, biomarkers and disease prevention. (2) Attract graduates of top Ph.D. and M.D.-Ph.D. programs to
cardiovascular research and (3) Provide opportunities for M.D.s in clinical fellowships at UCSF to obtain
rigorous research training. The Program brings together a diverse and outstanding group of mentors with a
common interest in cardiovascular biology within the Cardiovascular Research Institute at UCSF, a multi-
departmental and multi-disciplinary research organization. It places trainees in remarkably productive and
interactive laboratories. Multi-disciplinary affinity groups, largely co-located in the Smith Cardiovascular
Research Building, provide collaborations and co-mentoring to promote acquisition of the knowledge and skills
required for success. A major outpatient clinic for patients with cardiovascular diseases in the Smith building
helps drive integration of laboratory- and patient-based research.

Public health relevance
8. PROJECT NARRATIVE Cardiovascular diseases remain one of the main causes of premature death and disability in the U.S. and are of increasing importance in the rest of the world. Technologies and approaches to determine the basic mechanisms that cause disease are increasingly powerful but increasingly specialized. Multidisciplinary efforts that bring together investigators with complementary knowledge, tools and skills and integrate laboratory and patient-based research will be required to make progress. This Training Program offers an exceptional faculty in a strong multidisciplinary, collaborative environment at UCSF, a top biomedical research institution, to train future leaders in cardiovascular research.